CNS Viral Persistence and Neuropsychiatric Perturbations in HIV: Single cell and Molecular Interrogation

Project Abstract
Despite prolonged suppression of HIV on antiretroviral therapy (ART), eradication or sustained remission of the
infection has not been achieved. Low levels of HIV DNA are still detectable in peripheral blood mononuclear
cells (PBMC) from people living with HIV (PWH) taking ART, and cells containing rebound-competent virus can
reside in sanctuary tissue sites, including lymph nodes, gut, genital tract and the central nervous system
(CNS). In a study conducted within the AIDS Clinical Trials Group, we have recently used highly sensitive
virologic assays in living donors to detect HIV DNA in cerebrospinal fluid (CSF) cells in up to 50% on long-term
ART. Importantly, those with detectable CSF HIV DNA had poorer global cognitive function that those in whom
CSF HIV DNA was not detected. We have subsequently shown higher concentrations of HIV DNA in CD4+ T
cells from CSF compared to contemporaneous PBMC, and that atypical cell lineages including myeloid cells
may be infected in CSF. Finally, we have successfully used single cell transcriptomics to identify unique and
rare cell types in the CSF in PWH associated with HIV disease status and have further demonstrated the ability
to identify cellular transcripts enriched in PWH versus healthy controls. Critical gaps in understanding CNS HIV
persistence include what the characteristics and function of infected immune cells are in CSF, whether HIV
proviruses in CSF are intact and genetically compartmentalized compared to proviruses in blood, and how
these features relate to neuropsychiatric function of long-term HIV. Since the number of cells present in CSF is
low in PWH suppressed on ART, thorough, simultaneous characterization of the immunologic and virologic
landscape of the CNS has not been achieved. Using optimized lumbar puncture procedures and novel
molecular techniques, we have overcome these obstacles to both rigorously examine the phenotype of
CSF cells and thoroughly characterize the size, stability, intactness, and sequence diversity of persistent HIV in
CSF compared to blood. We will use single cell technology to measure the transcriptional and cytokine profile
of CNS cells combined with novel quantification of intact HIV DNA and single genome sequencing to discover
new correlations within the CNS reservoir. Most importantly, we propose to rigorously examine the cognitive
function and mental health of people living with HIV using sophisticated implementation of the new NIMH
Research Domain Criteria (RDoC) framework, and how differences in neuropsychiatric outcomes relate to
specific immunological and virological characteristics of the CNS in a diverse cohort of participants with a
range of neuropsychiatric comorbidity.

Public health relevance
Project Narrative Optimizing the mental health and cognitive abilities of people living with HIV-1 will require an understanding of the biological connections between these functions and HIV-1 infection in the central nervous system (CNS). We will examine, at a single cell or provirus level, the CNS disease profile of both viremic and antiretroviral therapy (ART)-suppressed participants over time. Discovery of the mechanism of how HIV-1 impacts the CNS will lead to innovative targeted therapies that could modulate immunological factors or block specific viral effects to improve neuropsychological outcomes even without total elimination of the CNS HIV-1 reservoir.